Impact of the Early Family Emotional Climate on Preschooler Emotion Dysregulation

PROJECT SUMMARY/ABSTRACT
In dual parenting households, a high degree of conflict and discord between parents poses unique and signifi-
cant risk for child emotion dysregulation, largely by undermining a child’s sense of emotional security and
safety in the family. Most research has linked interparental conflict to child dysregulation during middle child-
hood or adolescence. What is less clear is if and how interparental conflict during the first two years of life—
when children are heavily dependent on parents and highly sensitive to family dynamics—ultimately alters the
development of healthy emotion regulation skills. Interparental conflict during infancy and toddler age is ex-
pected to foster a negative emotional family climate and undermine responsive parenting, which is essential for
building emotional awareness and adaptive emotion regulation skills in children. However, research demon-
strates that deprivation (e.g., the absence of warmth) can be just as detrimental as exposure to threat and ad-
versity. Thus, considering the degree to which parents have a warm, affectionate, and intimate bond with one
another, and how this contributes to an enriching and secure family environment, has the potential to reveal
another vital aspect of the early family system in addition to interparental conflict dynamics. Children also differ
in their temperamental sensitivity to context, and attention should be paid to differences in susceptibility to
early environments shaped by interparental dynamics. Our objective in the proposed research is to determine if
and how qualities of the interparental relationship during the first two years of childhood ultimately impact the
development of child emotion regulation. Our central hypothesis is that both maladaptive conflict management
and (low) emotional intimacy in the interparental relationship spill over into parent-toddler interactions and un-
dermine processes that are critical for healthy emotion socialization of children, setting the stage for child emo-
tion dysregulation, particularly for children who are most sensitive to their environments. To achieve our objec-
tive, we will collect rich, multimethod data (i.e., interviews, behavioral observations, surveys, responsive eco-
logical momentary assessments in the home) across 4 waves spanning infancy (age 1 year) to preschool (age
3 years) in a large sample of 250 families. The expected outcome of this research is an unprecedented under-
standing of early familial pathways impeding or promoting child emotion regulation. Given that emotion dysreg-
ulation substantially increases risk for psychopathology and related adverse outcomes (e.g., poor physical
health, social deficits) throughout the lifespan, it is critical that we understand the optimal early family condi-
tions that support emotion regulation development for informing highly efficacious early childhood interven-
tions.

Public health relevance
PROJECT NARRATIVE The proposed research is aimed at determining how family relationship dynamics, stemming from the interpa- rental relationship and unfolding during the first two years of life, impact emotion socialization of children and the subsequent development of child emotion regulation in dual parenting households. Given that emotion dysregulation substantially increases risk for psychopathology and related adverse outcomes (e.g., poor physi- cal health, social deficits) throughout the lifespan, it is critical that we understand optimal early family condi- tions that support emotion regulation development for informing highly efficacious early childhood interven- tions.